Tools for Distance Delivery of an Evidence-based AD Family Caregiver Intervention

DESCRIPTION (provided by applicant): As the US population ages, Alzheimer's disease and related disorders (ADRD) will present an emotional and financial burden to an increasing number of families and the U.S. healthcare system. More than 75% of the care for persons with ADRD is provided by family members at home, who need ongoing support to manage the daunting physical and psychological demands of care. A 20+ year randomized controlled trial (RCT) demonstrated the many benefits of a counseling and support intervention for spouse caregivers, the NYU Caregiver Intervention (NYUCI). Most notably, the NYUCI substantially reduced caregiver's depressive symptoms, improved their physical health, and extended the time persons with ADRD remained at home by an average of 1.5 years (Mittelman et al., AG14634, formerly MH42216; See www.nrepp.samhsa.gov/programfulldetails.asp? PROGRAM_ID=122). The intervention is now being widely implemented, but there are barriers that prevent many caregivers from receiving its benefits, including geographic distance; impediments to older adults leaving their homes; and travel considerations for counselors which make it impossible to provide the NYUCI. This innovative Fast Track application has massive implications for social service delivery to older adults, because it will make it possible to delivr an in-person intervention which is already evidenced based to older adult caregivers who cannot currently be served. It will create the online reservation and management technology linking counselors with families as well as the evidence of effectiveness of providing such services via secure video teleconferencing vehicles. The proposed Telehealth Technology for Distance Counseling (TTDC) and related online educational training modules will connect skilled providers to the families of persons with dementia without regard to geographic location. Implications for rural healthcare delivery are particularly persuasive. To our knowledge, this will be the first large-scale TTDC to be developed and rigorously tested with a randomized controlled trial. We hypothesize that such a system, coupled with online training for providers and families on tele- counseling and distance caregiving, will have similar benefits to those achieved with in-person counseling during the original NYUCI RCT. The TTDC will include a scheduling system to link counselors to families at their mutual convenience and assure delivery in a cost-effective manner. The TTDC has the additional potential to transform ADRD care in ethnic and culturally diverse communities by connecting highly trained NYUCI counselors with specialized language and cultural skills to families who would not have access to these resources locally. This innovative technology has strong commercial potential not only for providing effective and efficient supportive services to rural and ethnically diverse populations, but also for a variety of other disease management areas. PUBLIC HEALTH RELEVANCE: This Fast Track effort develops and evaluates a Telehealth Technology for Distance Counseling (TTDC) and online educational training modules for the national tele-delivery of the evidence-based New York University Caregiver Intervention (NYUCI) model, a psychosocial intervention for families of those with Alzheimer's disease (AD). This effort is highly relevant to U.S. public health because the NYUCI has been shown to reduce depression in caregivers and delay nursing home placement by 1.5 years, on average, but is not widely available, particularly in rural America. Widespread tele-delivery of the NYUCI model made possible by the proposed TTDC and training could support increasing numbers of the 10.9 million family caregivers delivering nearly 75% of the home care for those with AD (Alzheimer's Association: 2010 Alzheimer's Disease Facts and Figures) and provide the evidence necessary to support the argument for agencies such as the Centers for Medicare and Medicaid Services (CMS) to allow billable counseling sessions over secure video teleconferencing vehicles.

Public health relevance
This Fast Track effort develops and evaluates a Telehealth Technology for Distance Counseling (TTDC) and online educational training modules for the national tele-delivery of the evidence-based New York University Caregiver Intervention (NYUCI) model, a psychosocial intervention for families of those with Alzheimer's disease (AD). This effort is highly relevant to U.S. public health because the NYUCI has been shown to reduce depression in caregivers and delay nursing home placement by 1.5 years, on average, but is not widely available, particularly in rural America. Widespread tele-delivery of the NYUCI model made possible by the proposed TTDC and training could support increasing numbers of the 10.9 million family caregivers delivering nearly 75% of the home care for those with AD (Alzheimer's Association: 2010 Alzheimer's Disease Facts and Figures) and provide the evidence necessary to support the argument for agencies such as the Centers for Medicare and Medicaid Services (CMS) to allow billable counseling sessions over secure video teleconferencing vehicles.